Structure, Function, and Engineering of RiPP Biosynthetic Enzymes

Project Summary
Ribosomally synthesized and post-translationally modified peptides (RiPPs) constitute a large
class of natural products with a wide range of biological activities, including anticancer,
antinociceptive, antiplasmodial, and antibacterial. The biosynthetic enzymes that convert linear,
inactive peptide substrates into constrained bioactive compounds are not well understood,
especially with regards to enzyme mechanism, substrate recognition and in their utility for
producing new derivatives. The Nair research group has been engaged in research to address
these questions for the past 18 years. We seek to carry out biochemical, structural biological, and
engineering studies on several classes of RiPP biosynthetic enzymes and address questions
regarding substrate recognition, and substrate tolerance. We anticipate that this work will be of
use not only towards the discovery of new therapeutic compounds but to enable the production
of both of improved versions of these bioactive compounds, as well as new to enable production
of peptide-based compounds for which the biosynthetic pathways are not known.

Public health relevance
Project Narrative This research plan focuses on understanding how potent bioactive molecules are made from simple peptide precursors. Knowledge gained from this proposal will allow the production of bioactive scaffolds, and possibly new therapeutics, with improved functions and properties.